INVESTIGATING TUMOR INITIATION AND INVASION IN PREMALIGNANT BREAST CANCER WITH SPATIAL SINGLE CELL GENOMICS

PROJECT SUMMARY
Ductal Carcinoma in situ (DCIS) and Atypical Ductal Hyperplasia (ADH) are the most common forms of early-
stage breast cancer and are non-obligatory precursors to invasive ductal carcinoma (IDC). Genomic studies of
tumor initiation and invasion in premalignant breast cancer represents a major gap in knowledge and have
been challenging due to several technical barriers, including the limited number of tumor cells in the ducts, the
logistical challenge of obtaining fresh or frozen tissues, and the lack of spatial resolution in standard genomic
methods. To overcome these challenges, we have developed cutting-edge single cell sequencing methods
to profile DNA, RNA and Epigenomics with spatial-resolution in human tissue sections. We have also
established a unique fresh DCIS tissue collection program at MD Anderson to procure viable cells from DCIS
patients directly after surgery for single cell sequencing to overcome logistical challenges in sample sources.
In our previous work, we applied these methods to study copy number evolution during invasion in
synchronous DCIS-IDC patients, which identified punctuated copy number evolution (PCNE) in the ducts and
revealed a multi-clonal model of invasion (Casasent et al. 2018, Cell). This proposal will greatly extend these
initial studies to study mutational, epigenomic and transcriptional reprogramming in the tumor cells and the
microenvironment during premalignant breast cancer progression. Our central hypothesis is that the evolution
of premalignant lesions requires initiating mutations and punctuated copy number evolution (PCNE), which is
followed by transcriptional and epigenomic reprogramming in tumor cells and the microenvironment that leads
to invasion. AIM1 will investigate breast tumor initiation in ADH and DCIS, while AIM2 will focus on tumor
invasion in DCIS and IDC, and AIM3 will study role of the tumor microenvironment in DCIS progression.
Candidate mutations identified in these aims will be functionally validated in vitro. Completion of these aims
will greatly improve our fundamental knowledge of tumor initiation and invasion in premalignant breast cancer
progression, which may lead to new biomarkers and diagnostic modalities for identifying ADH and DCIS
patients that will progress to invasive disease and is critical unmet clinical need. Our long-term goal is to
translate single cell sequencing technologies into the clinic, where they are poised to make a major impact on
the diagnosis and treatment of premalignant breast cancer patients. The proposed aims are directly aligned
with the mission of NIH to reduce morbidity and improve the quality of life for breast cancer patients through
early detection.

Public health relevance
PROJECT NARRATIVE Ductal Carcinoma In Situ (DCIS) and Atypical Ductal Hyperplasia (ADH) are the most common forms of premalignant breast cancers, however our basic understanding of the genomic evolution and molecular events that underlie tumor initiation, invasion and progression remains limited. This proposal will use cutting-edge single cell DNA, RNA and epigenomic sequencing technologies and spatially resolved genomic methods to improve our understanding of premalignant disease. Our proposal is directly aligned with the mission of the NIH to improve the quality of life and decrease morbidity in breast cancer patients, by increasing our knowledge of premalignant disease.